Genetic information flow in the Hallmarks of Aging: from system-level analytics to mechanistic interventions

ABSTRACT
Although aging is understood as a system-wide deterioration of cell and tissue function, it is nevertheless
associated with specific hallmarks, first introduced by López-Otín et al. in 2013. Because these hallmarks have
traditionally been studied in isolation, the relationships between them remain largely unknown, including
whether hallmarks emerge at different times or in a hierarchical manner, or whether certain hallmarks (or genes
therein) are the critical drivers of aging. We previously quantified the system-wide deterioration of cell function
using a statistical physics approach, showing that the information communicated in transcriptional regulatory
networks decreases with age. Here, we propose to investigate how this information loss is determined by the
interplay among hallmarks, using both system-wide analysis and mechanistic interventions. Specifically, we
aim (1) to map the trajectory, hierarchy, and impact of genetic information flow for each of the hallmarks of
aging over time and according to sex; and (2) to mechanistically validate the effect of age on the transfer of
genetic information. We will accomplish these aims using a combination of single cell RNA-seq data from
skeletal muscle cells in young, middle-aged, and old male and female mice; computational analysis built on
tools from statistical physics and information theory; targeted genetic inhibition/overexpression using local
shRNA approaches; and in vivo assessment of muscle functional integrity. This innovative approach will be
carried out by an interdisciplinary team comprising a stem cell biologist (PI), a theoretical physicist (co-PI), a
computational biologist (co-I), and a molecular biologist (co-I), the breadth of which enhances feasibility,
impact, and likelihood for success. The outcome of the proposed work will be a quantitative and mechanistic
understanding of how hallmark-associated genes and processes (de)stabilize regulatory network interactions
over an organism’s lifespan. Ultimately, we anticipate that this framework can be extended to predict an
individual’s biological age and to develop strategies to reprogram gene networks with the goal of preserving a
more youthful phenotype.

Public health relevance
PROJECT NARRATIVE A well-known consequence of aging is a decline in physical function. These declines are a manifestation of the cumulative effects of molecular- and cellular-level impairment that have been stratified into Hallmarks of Aging. Here, we will employ a novel bioinformatic strategy to evaluate the effect of aging on biomolecular communication across the Hallmarks. Next, we will evaluate the physiological relevance of our findings through a series of experimental studies in mice across the lifespan. Ultimately, we anticipate this framework can be used to: 1) predict an individual’s biological age and/or likelihood for future pathology and 2) develop strategies to re-organize, re-wire, and/or reprogram gene networks to preserve a more youthful phenotype.